Role of neurexin in social adaptation and amygdala plasticity

Project summary
Social relationships benefit mental and physical health, while poor quality social interactions are associated
with worse health and higher mortality. The abilities that underlie social function are impaired in Autism
Spectrum Disorder (ASD). There has been substantial progress in identifying genes that are associated ASD.
But the link between ASD genetic factors and core social disruptions is unclear. Even in non-ASD individuals it
is not clear how these genes influence social behavior. To understand how these genes influence social
behavior, we must uncover how they impact the neural circuits that underlie social function. Many key social
functions are traced to a network of connected brain regions that is similar in rodents and primates. This
presents an opportunity to determine the impact of high-risk ASD genes on the function of key connections
within this social network. Prior research demonstrates that prefrontal cortical (PFC) connections to amygdala,
particularly anterior cingulate (ACC) excitatory projections to basolateral amygdala (BLA), play a fundamental
role in encoding social information and motivating social behaviors. Social behavior must be flexible in
response to shifts of extrinsic conspecific behavior and intrinsic social drive. ACC-BLA guides behavioral
adaptations during these shifts. This behavioral flexibility likely requires synaptic plasticity. NRXN1 (Nrxn1 in
rodents) is a high confidence ASD gene, and Nrxn1 disruption replicably impairs social behaviors in rodents
and weakens PFC-BLA synapses. There is much known about the importance of neurexin 1 protein in synaptic
functions, but it is not understood why Nrxn1 disruption leads to social impairments. In this project we propose
that neurexin 1 at PFC-BLA synapses is positioned to influence synaptic plasticity during social experience. A
goal of this research is to determine if neurexin 1 impacts rodent social behaviors by preferential modulation of
ACC-BLA synapses. We hypothesize that nrxn1 has circuit-specific actions on ACC-BLA and, through this,
nrxn1 contributes to flexibility of social behavior and ACC-BLA plasticity. This will be tested using a
combination of acute interference with neurexin 1, gene knockouts and circuit-specific knockdown in rats, while
measuring social behaviors that rely on PFC-BLA integrity, BLA responses to social stimuli, and PFC-BLA
synaptic function. These studies will provide us with a new understanding of the role of neurexin 1 in
modulation of a PFC-BLA circuit that is required for social flexibility. This novel information would help bridge a
known genetic social influencer with the neurobiology of social function.

Public health relevance
Project Narrative Social behavior is a key element of mammalian function and impairments are a core feature of Autism Spectrum Disorders (ASD). There are known genes that influence social function, and genetic risk factors for ASD, but the influence of these genes on neural circuits of social behavior is mostly unknown. Understanding the impact of these genetic factors on these neural circuits is necessary to uncover how they influence social function.